Characterizing chromatin protein dynamics in HIV-1 latency with a CASPEX approach

PROJECT SUMMARY
This project aims to develop and apply CASPEX technologies to measure protein changes in cells latently
infected with HIV-1. CASPEX refers to the combination of a catalytically-dead Cas9 (dCas9) protein that can
localize to a specific genomic locus fused to an engineered ascorbate peroxidase enzyme (APEX2) that is
capable of biotinylating proteins within a sphere of proximity to the fusion protein. CASPEX enables the capture
of proteins and nucleic acids in proximity to a genomic locus defined by guide RNAs complexed with dCas9.
This powerful approach can be combined with mass spectrometry analysis to identify and quantify changes in
proteins associated with genomic loci in an unbiased manner.
HIV-1 latency represents the major barrier to developing new therapies for HIV-1 treatment and cure. The
molecular processes governing HIV-1 latency have been investigated using high-throughput genetics, small
molecule screening, and focused molecular biology studies. CASPEX has the potential to provide
complementary information regarding HIV-1 latency processes that can confirm prior work or open new avenues
of research. In this project, we will develop two CASPEX approaches and apply them to models of HIV-1 latency.
In Specific Aim 1, we will engineer cell line models of HIV-1 latency for CASPEX analysis and characterize
protein changes at integrated HIV-1 chromatin loci in response to latency reversal. Findings made in cell line
models of HIV-1 latency are not always recapitulated in vivo, so in Specific Aim 2 we will develop a novel
approach to apply CASPEX in primary CD4+ T cells. Successful completion of this project will advance the
molecular understanding of HIV-1 latency and latency reversal, potentially informing on the development of next-
generation therapies to treat or cure HIV-1 infection.

Public health relevance
PROJECT NARRATIVE HIV-1 infection results in an early establishment of a latently infected reservoir of cells that have integrated HIV- 1 DNA into their genomes but do not produce virus and are impervious to antiretroviral therapy. Cessation of antiretroviral therapy eventually results in viral rebound from this reservoir. This project aims to develop new technologies to study the molecular processes governing HIV-1 latency in order to inform the development of new therapies and to better understand the underlying biology.